Reward motivations associated with bullying trajectories

PROJECT ABSTRACT
Bullying is the most common form of youth abuse world-wide and is linked to profound, lasting, deleterious effects
to psychological, social, academic and health functioning. The cascading effects of bullying costs the US billions
of dollars annually, and current interventions produce only modest improvements. Longitudinal examinations of
the course of bullying show that behaviors vary over childhood, though early perpetration is thought to be a
particularly troubling predictor of continued antisocial behavior. A recent bullying intervention targeting altered
reward processes, specifically a preference for relative rewards (e.g. those earned at the expense of others)
shows promise. However, how trajectories of bullying relate to altered reward processing, and how perpetrators
process relative rewards in comparison to absolute rewards (e.g. money or points earned) is currently unknown.
Explicating the biobehavioral reward mechanisms contributing to bully perpetration may allow for the design and
implementation of more biologically-informed, empirically-supported interventions that can provide greater
reductions in bullying. The goal of this K99/R00 Pathway to Independence Award is to provide the applicant with
the training in longitudinal data analysis techniques to explain how trajectories of bullying relates to altered
reward processes, as well as training in designing fMRI tasks to identify altered reward mechanisms
related to bullying. Additionally, a primary focus of my training will be to conducting bullying research
translatable to intervention programming, by working with my co-mentor in interfacing with multiple agency
stakeholders involved in youth violence and maltreatment. To achieve these goals, I have assembled a
committee that will provide unparalleled mentorship, whom have extensive backgrounds in longitudinally
modelling youth behaviors (Drs. Barch, Jonson-Reid, Jackson, Luby, and Vaillancourt), designing fMRI tasks for
youth that assay specific mechanisms (Drs. Barch and Sylvester), and who have experience leveraging findings
from research into feasible interventions with broad cross-level (youth, parent, school, agency) buy-in (Drs.
Jonson-Reid, Barch, Luby, Vaillancourt, and Glenn). These training goals will allow me to test predictions about
trajectories of bullying in relation to absolute reward processing and pilot tasks capable of assessing
relative and absolute reward preference during the K99 phase. Results learned from this will inform the R00,
where I will test whether trajectories of bullying predict preference for relative vs. absolute rewards and
if bullying predicts increased neural response to relative vs. absolute rewards. Results from this proposal
will clarify reward processing alterations related to bullying, examine specificity to other behavioral problems,
and examine relative reward preference in relation to other explanations of bullying, setting the stage for the
testing of an intervention in a future R01. This proposal addresses important concerns about bullying, a mission
core to the NICHD mission, and provides the applicant with the foundation needed for a successful academic
career at a research-I university.

Public health relevance
PROJECT NARRATIVE Youth bullying causes immense suffering and current interventions tend to produce only small improvements in behavioral outcomes, suggesting a dire need to elucidate the biobehavioral mechanisms motivating perpetration. The proposed research assesses how longitudinal variation in bullying behaviors relates to responsivity to rewards, specifically testing the hypothesis that bullies are particularly focused on receiving relative rewards (e.g. gaining at the expense of others) compared to absolute rewards (e.g. money/points earned). The proposed work provides the first direct comparison of these reward mechanisms, and is coupled with rigorous statistical procedures to elucidate how altered reward functioning contributes to bullying and can be targeted by future interventions.